Liquid Chromatography Flash Oxidation (LC-Fox™) Protein Footprinting System

The GenNext Phase I SBIR submssion entitled “Liquid Chromatography Flash
Oxidation (LC-Fox™) Protein Footprinting System,” is responsive to the ackowledged
need for new and improved tools for higher order structural analysis (HOS) of
biopharmaceuticals. Hydroxyl radical foot-printing (HRPF) is a HOS analytical technique
that involves the irreversible labeling of a protein’s exterior by reaction with hydroxyl
radicals with subsequent MS analysis to identify the outer portions of the protein. When
applied to dynamically changing mixtures of conformation, HRPF fails to elucidate
individual conformers. Our LC-Fox Protein Footprinting is a new, bench-top method to
probe dynamic conformational heterogeneous mixtures that can be separated via
various forms of chromatography, including size exclusion (SEC), ion exchange (IEX),
and hydrophobic interaction chromatography (HIC). In Phase I we will create a
prototype system to be tested with isocratic SEC.
GenNext Technologies is the only company commercializing technology and
products for HRPF HOS analysis. Our overarching goal is to convert the HRPF process
from an academic research experiment into a broadly adopted and valuable HOS
analytical tool. Our LC-Fox system is predicted to make substantial impact in the field of
biopharmaceutical research / development, formulation, and drug delivery, as it will
enable the detection and characterization of unwanted conformers (and potential
adverse drug reactions) created during the genesis and introduction of new
biotherapeutics.

Public health relevance
The importance of biopharmaceuticals has created a need for improved analytics to facilitate biopharmaceutical research. Our Phase I SBIR proposal will create an improved means to study the higher order structure of heterogenoues mixtures of biological conformers facilitating proteomics and pharmaceutical research and development. Upon successful completion of our program, we will demonstrate the transformative nature of our new technology to positively impact biopharmaceutical research.